Cancer Genetics (CG)

The University of Michigan (U-M) Rogel Cancer Center (Rogel) Cancer Genetics (CG) Program is a group of
interdisciplinary researchers who seek to advance knowledge of the genetic and epigenetic mechanisms that
underlie cancer development and progression. Investigators in the CG Program perform basic and translational
research aimed at understanding the origins and nature of cancer, thereby leading to novel preventive and
diagnostic approaches as well as the improved clinical management of cancer patients. CG members are
actively involved in intra- and inter-programmatic interactions with researchers in the Basic Science, Clinical
Research, and Cancer Control and Population Sciences Programs. The work being done by CG members is
particularly relevant to five of the Rogel’s cross-cutting research themes, specifically i) molecular determinants
of cancer; ii) biomarkers; iii) genetics and gene environment, iv) targets and therapeutics and v) inflammation,
microbes, and immunity. With combined effort, the Program has generated important insights in cancer
development, diagnosis, treatment, and prevention. In the current proposal, three scientific aims are detailed:
1) Elucidate the genetic and epigenetic mechanisms of cancer development and progression, 2) Utilize novel
animal model systems for characterizing the impact of critical genetic alterations found in human cancers, and
3) Generate new knowledge for translation into effective strategies for prevention, early diagnosis, and
treatment. By focusing efforts on shared scientific interest across Rogel programs, in tandem with a
commitment to training as well as mentorship, CG Program members have generated a cohesive body of
knowledge that has yielded novel and important insights into the genetic and epigenetic mechanisms
underlying cancer initiation and progression. In keeping with these accomplishments, the Program seeks to
further advance the development of new strategies for preventing, diagnosing, and treating cancer.